Pain-induced impulsivity in rats and its mechanisms

Pain is a complex subjective process consisting of sensory, affective and cognitive components. Although much
effort has been made in developing rodent models for sensory and affective pain components, less is known
about models that represent the cognitive component of pain. The importance of studying the cognitive
component of pain is 2-fold: 1- certain features of the cognitive component, such as impulsivity, contribute to
psychiatric comorbidities that result from chronic pain conditions; and 2- impulsivity is a significant contributing
factor for the development of substance use disorders. It is critical to examine pain models that shed light on
the mechanisms and etiology of psychiatric and substance abuse comorbidities stemming from chronic pain and
opioid analgesics. Moreover, inclusion of females in examining pain-induced impulsivity is particularly important
as females are more prone in to develop various comorbidities during chronic pain states. This application
introduces the delay discounting task (DDT) as a rodent model of the cognitive component of pain. The DDT has
been used to demonstrate deficits in decision-making and impulsivity in models of psychiatric and substance use
conditions in rodents and in humans. Our preliminary findings suggest that male and female rats treated with
hind paw complete freund’s adjuvant (CFA)-induced inflammatory pain exhibit delay discounting (i.e. impulsivity)
that is blocked by morphine. The pain-induced impulsivity is sexually dimorphic as females show stronger
discounting than males. Over three aims, this proposal will examine the role of gonadal hormones, VTA mu-opioid receptors, and nucleus accumbens D2 receptor on CFA-induced impulsivity. This study is the first step
in examining a rodent model of pain-induced impulsivity and its underlying mechanisms. Findings from the
proposed studies will advance our understanding of the multifactorial nature of pain perception, as well as the
mechanisms that contribute to complications and comorbidities often associated with chronic pain conditions.

Public health relevance
Pain perception is a complex process that consists of sensory, emotional and cognitive components. To date, many studies have focused on examining the sensory and emotional components of pain, whereas less effort has been made in studying the cognitive component. One aspect of the cognitive component of pain is pain-induced impulsivity. Pain-induced impulsivity is a significant factor to examine as it contributes to the chronicity of pain and the long-term complications resulting from chronic pain conditions, including the development of psychiatric and substance use disorders. This application proposes to use the delay discounting task, a behavioral measure of impulsivity, to examine whether rats that experience chronic inflammatory pain exhibit impulsivity. The study will further examine the effects of morphine, male and female gonadal hormones, opioid and dopamine receptor effects in the brain of rats to gain a mechanistic understanding underlying pain-induced impulsivity.